Regulation of the cell proliferation by CRL ubiquitin ligases-diversity supplement

PROJECT ABSTRACT / SUMMARY
No changes from the parent grant.

Public health relevance
NARRATIVE No changes from the parent grant.